Developing Computational Tools for Predicting and Designing Function-Enhancing Enzyme Variants

Project Summary
The a priori prediction and design of efficient mutant enzymes are broadly recognized as a “Holy Grail”
in chemistry and biology because it will allow researchers to find effective enzyme variants to degrade environ-
mental pollutants, conduct late-stage functionalization of fine chemicals, and treat diseases. Directed evolution
has been widely applied to identify optimal enzyme variants for chemical reactions, but how to accelerate the
screening cycles remains a critical roadblock due to the unknown relationship between sequence, structure, and
kinetics for enzyme catalysis. To overcome this challenge, the PI has been developing three computational in-
frastructures: 1) an integrated enzyme structure-function database, IntEnzyDB, that provides clean and tabulated
data for data-driven modeling; 2) a new software module, RosettaQM, for evaluating enzyme-reacting species
interactions using quantum mechanical methods; and 3) a high-throughput workflow, EnzyHTP, that allows com-
putational screening of enzyme variants. Enabled by these tools, in this MIRA proposal, the PI emphasizes
advancing new computational tools to predict and design new enzyme catalysts. First, the PI will develop a
multistate kinetic scoring function to predict the influence of mutation on apparent enzyme kinetics by leveraging
the enzymology data stored in IntEnzyDB and the QM-based enzyme-reacting species interaction scoring in
RosettaQM (Project-1). The PI plans to develop a kinetic scoring function that accounts for contributions of mul-
tiple reactive states along a reaction pathway and is distinct from existing computational rational engineering
strategies that emphasize the stabilization of one hypothetical transition state. The multistate kinetic scoring will
be experimentally validated to predict efficiency-enhancing mutations for FR29 esterase for a proof of concept
and fluoroacetate dehalogenase FAcD for environmental pollutant degradation. Second, the PI will develop an
integrated enzyme predicting protocol that augments molecular simulations and machine-learning models to
design enzyme variants to accommodate non-native substrates for late-stage functionalization of drug-like mol-
ecules (Project-2). EnzyHTP will be further developed to incorporate machine learning models to achieve multi-
objective prediction of beneficial mutations, evaluating the impact of mutations on enzyme electrostatic environ-
ment, substrate positioning, substrate-enzyme interactions, and enzyme stability, solubility, and promiscuity. En-
zyHTP will be experimentally examined in the design of new group-transferases to accommodate S-adenosyl
methionine analogues for late-stage functionalization of everninomicin, a promising drug for treating a broad
spectrum of antibiotic-resistant bacterial infections. In summary, the proposed research will deliver enabling
computational tools for virtual prediction and design of function-enhancing enzyme variants for biomedical and
biocatalytic uses.

Public health relevance
Narrative: Natural enzymes present exquisite control of efficiency and selectivity of chemical reactions, but how to predict enzyme variants to transform non-native chemical processes is broadly recognized as a “Holy Grail” in chemistry and biology because it will allow researchers to find effective enzyme variants to degrade environmental pollutants, conduct late-stage functionalization of drug molecules, and treat food allergies. Directed evolution has been widely applied to identify optimal enzyme variants for non-native reactions, but how to accelerate the screening cycles remains a critical roadblock due to the unknown relationship between sequence, structure, and kinetics for enzyme catalysis. My research program emphasizes developing computational platforms for the identification of function-enhancing enzyme variants to transform non-native enzymatic reactions, with an ultimate goal of delivering enabling computational tools for virtual prediction and design of function-enhancing enzyme variants for biomedical and biocatalytic uses.